SIREN Administrative Supplement

Project Summary and Abstract
This supplement requests support of effort for key individuals that will allow Temple University Clinical Research
Hub for the Strategies to Innovate Emergency Care Clinical Trials Network (Temple-SIREN) to continue
operations for recruiting participants into emergency care research and to help implement SIREN trials at local
and regional Temple-SIREN performance sites. Supplemental support is requested to maintain operations
between the end of regular funding for the first 5 years of SIREN and start of the second 5 years of SIREN.
Uninterrupted support of the Hub will ensure successful enrollment of participants into the ongoing SIREN trials:
ICECAP, BOOST-3, and HOBIT. We will continue to support the ancillary studies for these trials: PRECICECAP
and Bio-BOOST at eligible sites. Administrative supplemental funding will allow us better fulfill the specific aims
of the project. Two major aims of the Temple-SIREN award are to 1) to provide site and project management
to expedite SIREN study start-up and to optimize patient recruitment and protocol adherence at Temple-SIREN
sites and 2) develop a regional system of biomedical researchers to compete for future NIH grants and to
study.

Public health relevance
Project Narrative The Temple-SIREN Hub and spoke hospital clinical research network benefits patients with acute illness and injury across our region. We request continued support of the on-going Temple-SIREN Hub operations to continue to support local and regional hospitals and EMS systems serving diverse populations work together to provide patients the opportunity to participate in cutting edge treatment-altering clinical research and improve health care throughout the region.